Clinical and functional assessment of glaucoma-associated mitochondrial gene variants to facilitate precision eye care

The NIH Precision Medicine Initiative was launched in 2015 with the goal of improving disease treatment and
prevention based on understanding of genes, environment, and lifestyle. As a first step towards this goal,
genome-wide association studies (GWAS), funded in part by the NIH, have identified 127 genes associated
with risk for developing primary open-angle glaucoma (POAG) across multiple ancestries. However, this has
not yet translated into personalized approaches for disease diagnosis, risk stratification, monitoring or
treatment of this common, blinding disease. This proposal describes a 5-year training program for a clinician-
scientist to develop a career focused on leveraging understanding of the genetic basis of glaucoma to optimize
clinical care for afflicted individuals. I am well-suited to tackle this important unmet need. I have a strong
research background in glaucoma genetics and continued this work under the mentorship of Dr. Janey Wiggs
during my glaucoma fellowship at Mass. Eye and Ear. Our preliminary data demonstrate that POAG patients
with high mitochondrial genetic risk scores have higher mean treated intraocular pressure (IOP) and markedly
increased prevalence of paracentral field loss compared to patients with low mitochondrial genetic risk. These
results suggest that POAG driven by mitochondrial risk variants may represent a distinct disease subtype with
specific clinical features. However, the underlying molecular mechanism is unknown and deep clinical
phenotyping is also warranted. In Aim 1, we will investigate the extent that individuals with high mitochondrial
pathway-specific polygenic risk scores (PRSs) display elevated IOP, retinal mitochondrial dysfunction, distinct
visual field loss patterns on archetypal analysis and greater susceptibility to environmental toxins that impact
mitochondrial function. In Aim 2, we will characterize the functional impact of mitochondrial gene variants using
disease-relevant primary cell strains (trabecular meshwork cells and retinal ganglion cells from human donor
eyes) and ex vivo perfusions. The proposed work is geared to lay the groundwork for tailored approaches to
disease monitoring and treatment for the subset of glaucoma driven by high mitochondrial genetic risk.
Importantly, the research aims and proposed career development plan will provide me with new skills in
statistical genetics and bioinformatics, clinical study design, deep clinical phenotyping, and functional
assessment of conventional outflow cells and retinal ganglion cells. I will have access to all resources
necessary to carry out the proposed work through Mass. Eye and Ear and the greater Harvard community. I
am fortunate to have an outstanding team of mentors with expertise in glaucoma genetics (Drs. Janey Wiggs,
Louis Pasquale, Ayellet Segre, and Jae Hee Kang), clinical data science (Dr. Tobias Elze), mitochondrial
function (Dr. James Handa), conventional aqueous outflow pathobiology (Dr. Daniel Stamer) and retinal
ganglion cell function (Dr. Donald Zack). Importantly, all members of my mentorship team are committed to my
career development and facilitating my transition to an independent, R01-funded clinician-scientist investigator.

Public health relevance
Genetic studies involving thousands of individuals have identified many genes associated with glaucoma risk, though this has not yet translated to personalized approaches for diagnosis, monitoring or treatment of this common, blinding disease. This mentored clinician-scientist career development proposal will investigate the clinical impact and underlying disease mechanisms for glaucoma-associated genes that function in the mitochondria, the energy-producing parts of our cells. The approach is designed to help pave the way for personalized glaucoma care for individuals whose disease is driven by mitochondrial gene variants; the methodologies employed in this proposal can also be readily applied to other genes and pathways in the future to lay the foundation for precision glaucoma care.